Probing ER stress signaling with orthogonal control of receptor oligomerization

Project summary
The unfolded protein response (UPR) is a critically important signaling network that is responsible for
maintaining the health of the endoplasmic reticulum (ER). While the typical outcome of UPR activation is
cytoprotective, prolonged or excessive UPR activity can drive cells towards apoptotic death. The UPR serves as
a potent controller of cell fate, and its dysregulation is known to be implicated in a broad range of human diseases
such as diabetes, neurodegeneration, autoimmune disorders, and cancer. The UPR comprises three
interconnected branches that exhibit spatiotemporally distinct patterns of activation both in normal development
and in disease. A lack of understanding of how the UPR is differentially regulated in different cell types and
tissues has so far precluded it from being successfully targeted in human patients.
The best-studied branch of the UPR is mediated by the ER membrane-resident bifunctional kinase-RNase
IRE1 (inositol-requiring enzyme 1). Recent work demonstrated that IRE1 signaling is closely tied to adhesion,
cell migration, and cells’ ability to receive and respond to external cues. Cell signaling is often coupled to
mechanical and chemical changes in the local microenvironment, but the involvement of IRE1 and the UPR in
this coupling is only beginning to be revealed. Since UPR components are ubiquitously expressed in nearly all
cell types, context-dependent regulation offers an attractive potential explanation for the observed large
variances in UPR signaling across tissues. However, it remains to be determined what properties of the local
environment cause cells to rely on UPR signaling and how this information is communicated.
I propose to build on the tools I developed as a postdoc and on the unique combined resources of my two
co-mentors to answer these challenging and exciting questions. I will engineer precisely defined growth
substrates of varying chemical composition, porosity, stiffness, and 3-dimensional organization. I will then use
chemical inhibitors and optogenetic activators of IRE1 to identify which substrate properties render cells reliant
on IRE1 signaling and which properties render IRE1 dispensable. Substrate dependence of IRE1 signaling will
be functionally separated from general UPR activation and mapped to specific nodes within the UPR. Finally, a
targeted approach will identify the specific molecular players responsible for the information flow between ER
stress sensors and the extracellular environment.
Throughout the mentored phase of the award, I will continue to hone my skills and qualifications as an
independent scientist. Working closely with the lab of Dr. Valerie Weaver will provide me with the expertise in
cellular mechanobiology and substrate engineering, complementing the deep background of my primary mentor,
Dr. Peter Walter, in UPR signaling. Learning how information flows between the ER and the extracellular matrix
will reveal exciting new cell biology, result in possible therapeutic applications, and serve as a strong foundation
for an independent research program in my future laboratory.

Public health relevance
Project Narrative The unfolded protein response (UPR) is an interconnected signaling network that monitors and regulates the health of the endoplasmic reticulum (ER) in mammalian cells. This proposal seeks to investigate the mechanism behind the recent observation that activation of the UPR is linked to cells’ physical interactions with their environment. Dysregulation of the UPR is implicated in a broad range of diseases, and learning how this pathway integrates local external cues will advance our understanding of basic cell biology while revealing new tissue- specific therapeutic windows.